PHASE III TRIAL OF CRISNATOL MESYLATE VS BCNU IN BRAIN TUMOR PATIENTS

The primary objective is to determine whether Crisnatol Mesylate is superior to BCNU as measured by time to tumor recurrence or progression in patients with glioblastoma multiforme. A secondary objective is to determine whether Crisnatol is superior to BCNU as measured by overall survival in patients with glioblastoma multiforme.